Proximal Tubule Alternative Splicing and Progression of Diabetic Kidney Disease

ABSTRACT
Diabetes mellitus affects ~10% of the U.S. population and diabetic kidney disease (DKD) is the leading cause
of end stage kidney disease (ESKD) worldwide. Despite recent treatment advances, only a limited reduction in
rates of ESKD from DKD have been observed. While sodium-glucose cotransporter 2 inhibitors (SGLT2i) have
emerged as a promising drug class for the treatment of DKD, their mechanism of action remains unknown.
Understanding the renoprotective effects of SGLT2i will inform the development of future therapeutics. Recent
work from our laboratory generated a single nucleus RNA-sequencing (snRNA-seq) atlas of a murine model of
DKD and response to five different treatment regimens, including SGLT2i. This ~1 million cell dataset revealed
that diabetes downregulated the spliceosome regulator Srsf7 in PT and its expression was specifically rescued
by SGLT2i - but not other therapeutic regimens. The spliceosome regulates alternative splicing, a process that
increases transcript diversity by generating multiple variant mRNAs from one gene. We further found that DKD
drove changes in alternative splicing in vivo, and in vitro, PT knockdown of Srsf7 triggered alternative splicing
of ~250 genes and differential gene expression inducing a pro-inflammatory phenotype. There is surprisingly
little known regarding alternative splicing in both kidney health and disease. Based on our preliminary data, we
propose that DKD induces tubulointerstitial fibrosis by downregulation of the spliceosome gene Srsf7 in the S1
segment of the PT, leading to a pro-inflammatory and pro-fibrotic transcriptome. We further hypothesize that
alternative splicing is a broader PT response to chronic injuries that is conserved in humans. We propose the
following investigations to critically test the importance of alternative splicing in regulating the proximal tubule
injury response to the diabetic milieu and chronic kidney disease: Specific Aim 1: Define and validate the
spectrum of alternative splicing in DKD and treatment with SGLT2i using long-read RNA sequencing. Long
read sequencing is critical for accurate quantitation of alternatively spliced isoforms and has never been
performed in DKD models. Specific Aim 2: Test the hypothesis that hypoxia drives PT alternative splicing via
downregulation of SRSF7. Our preliminary data indicates that PT cells exposed to hypoxia or a hypoxia
mimetic downregulate SRSF7, and cells with SRSF7-knockdown have decreased cell proliferation and
upregulation of inflammatory pathways. Specific Aim 3: Determine whether regulation of alternative splicing
occurs in human DKD and whether Srsf7 is required in the proximal tubule to promote a `healthy'
transcriptome. Whether or not alternative splicing in kidney occurs in human DKD is unknown, and whether
Srsf7 is required for PT homeostasis is undefined.

Public health relevance
Project Narrative: Diabetes mellitus affects ~10% of the U.S. population and diabetic kidney disease is the leading cause of end stage kidney disease worldwide. We hypothesize that diabetes drives changes in the ways that genes are turned into proteins in a specific compartment of the kidney called the proximal tubule. We will study regulation of this process, called alternative splicing, to better understand how diabetes leads to kidney fibrosis and ultimately kidney failure.